SURFACE MODIFICATION USING DEXTRAN FOR IMPROVED BIOCOMPATIBILITY: CELL ADHESION

XPS is used to characterize dextran-coated glass coverslips. The dextran is immobilized by activating its hydroxyl groups and then covalently attaching it via the activated groups to the substrate. Once immobilized, the remaining activated functional groups on dextran can be used for attachment of molecules such as peptide sequences for specific cell-type recognition.